Preventing Adult Mental Health Problems from Early Childhood in the Contexts of Genetic Susceptibility, Poverty, Racism, and the COVID-19 Pandemic

ABSTRACT
Early adults are experiencing high rates of mental health issues, including anxiety, depression, suicidality, and
psychosis. The overall goal of the NIMH-funded R01 Early Steps Multisite parent grant is to examine the
impact of randomization to receipt of the Family Check-Up (FCU), or not, from child ages 2 to 10 on
developmental pathways from early childhood to early adulthood, focusing on mental health disorders and
symptomatology in emerging adults. Aligned with the third aim of the Early Steps parent grant, “to examine
the long-term preventive effects of the FCU on mental health, in the context of growing up in poverty,” this
supplement proposes an extension of this aim, specifically focusing on various aspects of living in poverty in
early childhood (caregiver income, employment, education, and financial stress) as independent contributors
to risk for self-reported mental health symptomology in adolescence and early adulthood, and if these
relationships are mediated by maternal depression and caregiver competence in childhood, and moderated by
the FCU intervention. We also plan to examine this model with mental health care utilization, for those
experiencing mental health issues, in adolescence and adulthood as the outcome. Findings from this study will
contribute to understanding of how specific aspects of growing up in poverty may exacerbate or ameliorate
mental health symptomatology in adolescence and adulthood, and how the FCU may buffer the impact of
childhood poverty on later mental health and utilization of mental health care. Overall, the research and
training Dr. Chirimwami will receive as part of this diversity supplement will accelerate his transition to an
independent research scientist by expanding his expertise in childhood poverty, work with underserved
communities, the impact of the FCU intervention, longitudinal modeling, and scholarly and grant writing.

Public health relevance
PROJECT NARRATIVE Utilizing the longitudinal Early Steps Multisite prevention trial of diverse, low-income families (N=731) from three geographic areas across the United States, we plan to take advantage of an 18-year-long prospective dataset in conjunction with new mental health assessments to examine risk and resilience factors for at-risk emerging adults. In this Diversity Supplement, we plan to examine direct, interactive, and cascading effects on mental health outcomes, including mental health care utilization for those who are experiencing mental health symptomatology, and the long-term preventive effects of the Family Check-Up, in the context of growing up in poverty.